FRESH Network: Assisting Ozark School District with Understanding Contaminants in School Meals and Transitioning to Better Food Systems

Project Abstract:
This project seeks to investigate the presence of contaminants in school meals and their
connection to ultra-processed food consumption, nutrition, and overall student health. With
Arkansas ranking among the highest in the nation for childhood obesity and food insecurity, this
research could not be more urgent.
Our team will conduct a yearlong comparative study of vendor-provided, ultra-processed meals
and scratch-cooked, farm-fresh alternatives. We will test for contaminants such as sodium,
preservatives, heavy metals, and nitrates, while simultaneously tracking student responses,
food waste, and engagement.
Through three seasonal survey rounds and hands-on focus groups, we will engage students,
kitchen staff, and families to assess perception, alertness, and satisfaction. This will be paired
with curriculum-aligned materials to support classroom integration in Career & Technical
Education (CTE) programs.
Participating schools will receive support in developing healthier dishes, collecting data, and
purchasing kitchen equipment such as combi ovens to increase their capacity for scratch
cooking. Graduate researchers will assist with data collection and reporting, and public
dashboards will share outcomes in real time.
We are especially focused on equity and access, prioritizing rural and under-resourced schools
that often lack the infrastructure to improve their meal programs. Arkansas, a state with a $21
billion agricultural industry, is uniquely positioned to lead the nation in school food reform.
This collaborative effort includes Thaden School, Healthy Flavors, University of Arkansas
Extension, and school districts ranging from Ozark to Cabot, all aligned in a shared mission to
transform what’s possible in the cafeteria.
We respectfully request your support for this initiative—one that uplifts communities, protects
children’s health, and lays the foundation for a national school food model rooted in
transparency, nutrition, and dignity.

Public health relevance
In Arkansas, where childhood obesity and food insecurity are among the highest in the nation, schools are working to transform cafeteria meals from ultra-processed to nourishing, scratch-cooked options. This project supports that transformation by funding equipment, curriculum, and nutritional testing while engaging students in hands-on food education. By connecting farms, classrooms, and kitchens, the initiative empowers schools to serve healthier meals and build lifelong habits for well-being.